NEUROPSYCHOLOGICAL MECHANISMS OF ADHD

Young adults with Attention Deficit/Hyperactivity Disorder (ADHD) have an increased incidence of automobile crashes and are typically responsive to Ritalin. It is unclear whether these patients have EEG abnormalities and whether Ritalin corrects EEG abnormalities and driving impairments. Using a 2 (ADHD-No ADHD) X 2 (Ritalin-Placebo) radomized, double blind, cross-over design, this study investigates whether new driving simulation and EEG capabilities differentiate young adults with and without ADHD, on and off of Ritalin.